EARLY BILIRUBIN TOXICITY USING BAERS AND UNBOUND BILIRUBIN INDICES

To describe the correlation between changes in brainstem auditory evoked responses and the apparent unbound bilirubin concentration and hematofluorometer in term infants with hyperbilirubinemia.